High Performance Gradient System for Advanced MRI Neuroimaging

Project Abstract
We request funds to upgrade our current Siemens MAGNETOM Prisma 3T MRI scanner (installed in 2014) to
the Siemens MAGNETOM Cima.X Fit 3T MRI scanner. The Cima.X Fit scanner is a commercialized
connectome scanner, designed for advanced neuroimaging, with a gradient system of 200 mT/m, whose
prototypes were developed by Siemens Healthineers in collaboration with Massachusetts General Hospital,
Cardiff University, and the Max Planck Institute for the human connectome project (HCP). Our request for an
MRI system upgrade is driven by the need for advanced diffusion imaging techniques to probe brain and other
tissue microstructures with greater detail and specificity and the need to leverage AI-assisted fast imaging. The
gradient strength limitations of our current Prisma scanner prevent us from pursuing cutting-edge diffusion
microstructural imaging. Over 90% of our projects utilize diffusion-weighted MRI. Building on our strong and
well-funded neuroimaging program, the high-performance gradient system will elevate our research
capabilities by enabling the bench-to-bedside translation of high-resolution and advanced diffusion MRI
technologies that are unavailable to us now. The high-performance gradient system will allow us to move
beyond conventional diffusion tensor imaging (DTI) with non-specific metrics and apply biologically specific
metrics (e.g., soma fraction, neurite density, and axonal diameter) to our large clinical populations. This will
enhance our translational science by further bridging the gap between basic neuroscience research on our
preclinical small animal 9.4T MRI scanner and human imaging studies. In addition, the current MRI pulse
sequence software has become obsolete, preventing us from applying advanced fast imaging technologies
using compressed sensing and AI-assisted reconstruction. Fast imaging improves all our imaging studies
(including neuro and body imaging), and shorter scan times, while maintaining image quality, will markedly
reduce the participant burden. This is particularly important for neonates, older adults, and other clinical
populations who may have difficulty tolerating longer scans.

Public health relevance
Project Narrative The Indiana University School of Medicine hosts leading NIH-funded research institutes and centers conducting pioneering research on neurological diseases, Alzheimer’s, traumatic brain injury, vascular contributions to cognitive impairment (VCID), substance use disorders, cancer, cardiology, and pediatric medicine, among many others. High-quality, fast neuroimaging and body imaging MRI is critical for the success of these research programs. A high-performance MRI system with advanced gradient capabilities, fast image acquisition, and AI-assisted reconstruction will significantly enhance our research by providing increased precision, accuracy, and rigor.